Columbia University NCI Community Oncology Research Program

Project Summary
The Herbert Irving Comprehensive Cancer Center’s NCORP program at Columbia University Irving Medical
Center (HICCC/CUIMC/NCORP) has developed a robust and sustainable infrastructure to support the
activation and accrual of NCI Clinical Trials Network (NCTN/NCORP) studies. Our program is dedicated to
extending high-quality cancer care and clinical trial access to populations within our designated catchment
area, particularly those facing limited access to research and comprehensive care.
The program’s core aims are to:
1. Expand access to a comprehensive portfolio of NCI-supported trials in cancer prevention, screening,
treatment (Phases I–III), care delivery, and biospecimen collection;
2. Enhance accrual by addressing barriers to participation and increasing awareness and availability of
trials;
3. Lead and contribute to NCORP/NCTN research efforts, especially those that improve access and
reduce the burden in cancer outcomes;
4. Collaborate with NCORP-wide initiatives to drive innovation across the national cancer research
landscape.
Over the past six years, HICCC/CUIMC/NCORP has activated over 143 trials and enrolled more
than 1,513 patients across key focus areas. We have consistently exceeded accrual benchmarks and have
taken on leadership roles in multiple national studies. These outcomes reflect the program’s strong integration
of research with community engagement and clinical care delivery.
By expanding clinical trial access for patients in communities with limited care, we are making measurable
progress in reducing outcome gaps and ensuring that advances in cancer care reach all populations.

Public health relevance
Project Narrative The goal of this initiative is to reduce the cancer burden within our NCORP-designated catchment area by expanding access to clinical trials for populations that have historically faced barriers to research participation. We will contribute to the development of NCORP trials nationally while leading local efforts to educate patients and providers about opportunities in cancer prevention, control, care delivery, and treatment research. By increasing trial awareness and participation across our catchment area, we aim to advance access to high- quality cancer care and improve outcomes at the community level.